Renal and Epithelial Biology Training Program

The goal of this training program is to prepare predoctoral students, physicians and PhDs for biomedical
research careers by providing a concentrated, in-depth research experience. This program is designed to
foster a rigorous approach to scientific inquiry in basic science or clinical investigation. Four areas of research
are emphasized: (1) epithelial transport/hypertension; (2) epithelial cell biology; (3) cell signaling/kidney and
lower urinary development/kidney and lower urinary tract pathophysiology/immunology; and (4) renal
epidemiology/clinical research/genetics. Our training program faculty are members of the University of
Pittsburgh. Together they form a well-integrated and collaborative entity dedicated to research training and
investigation in nephrology and epithelial biology. Trainees will develop a research project under the close
supervision of a faculty trainer and will be closely monitored by an independent advisory or dissertation
committee, as well as by the research training executive committee. Didactic lectures, research seminars,
journal clubs, formal course work and attendance at scientific meetings will supplement this intensively
structured research experience. Predoctoral graduates of this comprehensive training experience will be
equipped to compete for individual training support. Postdoctoral graduates of this program will be prepared to
compete for independent funding and entry-level faculty positions in academic medicine.

Public health relevance
Our training program fosters a rigorous approach to scientific inquiry in the areas of basic, translational and clinical investigation. Our trainees publish novel science, attain fellowship and career development awards, and transition to independent research careers. Our goal is to train a new generation of scientists to be future leaders in the fields of nephrology and epithelial biology.